RECRUITMENT CORE (RC)

The goal of the recruitment core is to maximize efficient enrollment into the clinical trials of the ADCS. The ADCS has engaged in many activities to increase participation in the past, working with Project Directors, Local Sites and with the general public. While several trials have recruited rapidly and efficiently, others have been difficult to recruit. In this application we propose to organize our recruitment efforts across all projects. We propose to expand the type of efforts, evaluate both new and previously tried recruitment approaches, modify based on the evaluation and re-evaluate. These efforts will be developed within specific trials but will use assessment techniques across trials. Specific Aims are to identify a full range of recruitment activities, both previously tried and newly developed. Specific activities would include use of focus groups with targeted populations to establish how we package the message about each trial;Direct Mail to targeted audiences to maximize exposure, Web based communication that is designed to maximize ease of participation and toll Free phone numbers with automated answer. Other activities include study specific Public and Professional Endorsement via direct work with Site staff at 3 levels: 1) Identify activities for PI that are associated with high recruitment 2) Provide guidance for selecting effective recruitment staff and other study personnel 3) Provide staff development opportunities. All activities will be evaluated and modified based on feedback from the modification.